Development of novel antivirals for arthritogenic alphaviruses

Project summary: Development of Antivirals for Arthritogenic Alphaviruses
This NIH grant proposal aims at the optimization of a New World (NW) alphavirus-specific quinazoline
scaffold for the development of an anti-Old World (OW) arthritogenic alphavirus therapeutic candidate. With a
particular focus on Chikungunya virus and other alphaviruses with a pandemic potential, this project responds
to an urgent public health need for effective antiviral treatments for OW alphaviruses, given the recent increase
in global prevalence of OW alphavirus infections.
Dr. Chung's research group has made significant advancements in developing a quinazolinone-based
antiviral specifically targeting NW alphaviruses like Venezuelan Equine Encephalitis Virus, exhibiting
remarkable efficacy in preclinical models. This success, coupled with the compound's unique mechanism of
action targeting the viral replicase complex, positions the quinazoline scaffold as a valid starting point for
developing effective antivirals for other alphaviruses. However, the compound series necessitates significant
enhancement in potency against OW alphaviruses. The team has identified a key residue that contributes to
the NW alphavirus-specific antiviral spectrum. Here by elucidating the molecular interactions and clashes
between the quinazolinone scaffold and OW alphavirus replicase complexes, the team aims to develop next-
generation inhibitors with enhanced efficacy toward OW arthritogenic alphaviruses.
Recognizing the need to enhance the potency of the quinazoline series against OW alphaviruses, the
project proposes three Specific Aims undertaking a comprehensive and systemic approach integrating
structural insights, medicinal chemistry, and preclinical evaluations. Dr. Luo's work in Specific Aim 1 focuses on
mapping molecular interactions and clashes between the current quinazolinone scaffold and the OW
alphavirus replicase complex, providing critical structural insights that will inform the design of new inhibitors in
Specific Aim 2 led by Dr. Bannister. Specific Aim 2 efforts are directed towards identifying chemical groups
leading to resistance in OW alphaviruses, designing and synthesizing new compounds tailored for OW
alphaviruses, and ultimately developing lead candidates with optimized pharmacological profiles. Dr. Chung, in
Specific Aim 3, will assess these novel antivirals in vitro and in vivo, supporting the structure-activity study for
Aim2. Aim 3 will also study the mechanisms of action and resistance of the series.
The overarching goal of the project is to deliver novel, potent therapeutic candidates for OW arthritogenic
alphaviruses. With a highly integrated team of experts and a meticulous approach spanning molecular
structural biology, medicinal chemistry, and virology, this project holds the promise of advancing preclinical
development, ultimately addressing a critical gap in public health preparedness against OW alphavirus
infections. Upon successful completion, the project will deliver promising therapeutic candidates ready for
advanced preclinical development to address the critical needs for arthritogenic alphaviruses therapeutics.

Public health relevance
PROJECT NARRATIVE: Development of Antivirals for Arthritogenic Alphaviruses This NIH grant proposal is to advance antiviral drug discovery against Old World arthritogenic alphaviruses with a pandemic potential. By utilizing state-of-the-art methodologies and leveraging our deep understanding of the mechanism of action of a previously developed potent anti-encephalitic New World alphavirus candidate, our research aims to develop robust antiviral compounds and facilitate the development of effective therapies against arthritogenic Old World alphaviral infections. This project addresses a critical gap in public health and contributes to the NIH pandemic preparedness program.